Rapid Autopsy

PROJECT SUMMARY/ABSTRACT
Postmortem examinations of patients, where the procedure commences shortly after death (rapid
autopsies), are becoming an important scientific engine for understanding mechanisms of disease progression
and drug resistance, especially in this era of personalized medicine and immunotherapy. The Johns Hopkins
Legacy Gift Rapid Autopsy Program is a Sidney Kimmel Comprehensive Cancer Center (SKCCC) Rapid
Autopsy Program (RAP) Shared Resource (SR). It has been highly successful and was growing steadily prior
to the onset of the SARS-CoV-2/COVID-19 pandemic. Services provided by the RAP SR include: 1)
performing rapid research autopsies on patients who die of cancer to improve our understanding of tumor cell-
intrinsic and tumor microenvironmental molecular alterations associated with disease progression,
heterogeneity and drug resistance, including resistance to biological agents and immunotherapeutics; 2)
providing histopathological expertise for diagnostic and quality control/assurance in interpretation of autopsy
samples, including fresh frozen tissues and formalin-fixed paraffin-embedded (FFPE) tissues; 3) conducting
biospecimen science studies to aid in the development and extension of best practices for consenting, tissue
procurement, derivative specimen handling and sample storage; 4) expanding and maintaining a biorepository
of fresh frozen and FFPE tissues, multitumor tissue microarrays, and fluid specimens from rapid autopsy
cases, with full pathology and clinical annotations that can be accessed by qualified SKCCC and other
investigators; and 5) developing and maintaining a web-based, secure and sharable whole-slide imaging
archive of rapid autopsy histopathology and molecular pathology specimens.
SKCCC Managed Shared Resource
Reporting Period: January 1, 2020 to December 31, 2020